IDENTIFYING ROADBLOCKS TO LIMB REGENERATION

PROJECT SUMMARY (ABSTRACT)
Humans have exceedingly limited natural limb regenerative abilities. Limb loss due to injury or disease
is a major health problem. About two million Americans currently live with the consequences of limb loss, and
this number is expected to rise because of increased prevalence of key risk factors such as diabetes and other
diseases that affect vasculature. The consequences of amputation are profound for patients and most must
rely on prosthetics, which are not perfect. A regenerative medicine approach may one day be feasible if it were
understood how total limb replacement can be naturally achieved. To gain this understanding, we are
employing an animal model, the axolotl salamander, which can completely regenerate limbs following
amputation, even as adults. Axolotl limbs are anatomically similar to human limbs, and their initial development
is similar as well. Thus, they offer a blueprint for how a complex, three-dimensional limb can be regrown and
functionally integrated into the existing stump following amputation. Key issues that must be resolved if this
paradigm is to be translated into the human forum are how axolotls activate and cultivate the progenitors for
the new limb. Additionally, the cellular and molecular forces that might antagonize successful regeneration
must also be understood as these might normally exist in human patients and thereby prevent regeneration.
Future research could elucidate whether the molecular and cellular forces guiding these events are not
activated in mammals, or whether they terminate prematurely, or whether they are overtly blocked by other
factors. The approach is to first thoroughly understand how limbs do regenerate, and then later use this
information to develop hypotheses for future possible therapies.
In this proposal, we leverage our recent finding that axolotls can be compromised in their ability to
regenerate limbs following repeated amputation. This finding presents a unique opportunity to identify factors
that may be limiting in regeneration or may antagonize it. We will examine activation of progenitor cells
following successive amputations to determine if these cells are exhausted in regenerative failure. We will also
consider the role of macrophages and myofibroblasts in regenerative failure following repeated amputation. We
will test if the regenerative limitations we uncovered operate at a local level, within the limb itself and close to
the site of amputation, or if they act more systemically, elsewhere in the body. Finally, we will investigate the
activities of two genes whose expression becomes dysregulated following repeated amputation, amphiregulin
and eyes absent 2, both of which have human correlates. This research will capitalize on the opportunities
presented by our new model with the hope that increased understanding of regenerative limitations will be
essential for future regenerative medicine approaches in patients.

Public health relevance
PROJECT NARRATIVE Humans have exceedingly limited natural limb regenerative abilities, limiting available regenerative medicine therapies for the millions of patients suffering from limb loss due to injury or disease. Here, we leverage the power of axolotl salamanders, whose limbs are similar to humans but naturally regenerate fully after amputation, to gain insight into the process and enable development of future therapies. We have developed a model in which axolotls fail to regenerate following repeated amputation, and we use this model to elucidate mechanisms of regenerative failure—representing potential roadblocks to the process—at the cellular and genetic level.